CORTICAL PROCESSING OF GUSTATORY INFORMATION

The purpose of this study is to determine how the brain processes taste information. The study will include both healthy individuals and those who have had a stroke or other brain injury.